EVIDENCE BUILDING IN TANF: ADVANCING INNOVATIONS TO PROMOTE EMPLOYMENT AND ECONOMIC SECURITY FOR LOW-INCOME INDIVIDUALS

The purpose of this project is to strengthen ACF’s understanding of effective interventions aimed at supporting low-income individuals find jobs, advance in the labor market, and improve their economic security. The project will build the evidence base in this area by: ? Conducting a series of rigorous federal evaluations of innovative programs designed to promote employment and build self-sufficiency for low-income individuals. ? Supporting states in moving toward rigorous evaluation of such programs, at a state level. ? Prioritizing evaluations of programs that work with individuals struggling with opioid dependency, abuse of other substances, and mental health issues. Interventions that are candidates for evaluation may include programs that serve TANF recipients or, more broadly, individuals and their families who are at risk of TANF dependency. The project will select interventions that have already been fully implemented, undergone formative evaluations or assessments resulting in a logic model, or have shown some significant impacts in summative evaluations, allowing this project to increase the number of evidence-supported interventions in this area.